Integrated Health Service Facility Core

Integrated Health Sciences Facility Core
Abstract
The specific objectives of the Integrated Health Sciences Facility Core (IHSFC) are to: 1) Provide the services,
instrumentation and technologies needed for basic and applied environmental health research, including
population-scale genomics, cell and molecular analytics, and environmental exposures and chemistry; 2)
Support translational research to improve exposure characterization, early detection of disease risk, biomarker
discovery and development of preventive interventions for environmentally related diseases; 3) Provide training
in methods and technologies to present and future environmental health scientists. To achieve these goals, the
IHSFC consists of the Bioanalysis, Environmental Genomics, and Microbiome Services. Each service
provides: 1) scientific expertise and advice to Center investigators on how to best accomplish their goals; 2) in-
house instrumentation and equipment, as well as technical staff and expertise for biological and environmental
studies; 3) access to an extraordinary menu of other analytical services in the Harvard Medical area, the
Harvard-Cambridge campus, and beyond. The IHSFC supports the translational mission of the Center by the
analyses performed, by optimizing efficient use of valuable samples from subjects in population studies, and by
assisting investigators in finding and using analytical resources for their needs. Each IHSFC service also trains
students, post-docs and other environmental scientists in the technologies offered. The overall benefit to the
Harvard Chan School-NIEHS Center is expertise and provision of analyses, assistance with translation of
research and the training and development of future environmental health scientists.